MOLECULAR PHARMACOLOGY OF ANTICANCER DRUGS

This proposal is to continue studies to elucidate the detailed molecular mechanisms by which certain antitumor antibiotics damage DNA and interfere with DNA function. Not only will this work contribute to our understanding of how anti-cancer agents work, but should lead to the development of drugs with increased selectivity for neoplastic cells and lowered toxicity for the host. Important byproducts will be the uncovering of novel mechanisms of DNA damage and repair and of mutagenesis, and the development of new probes and tools for the study of gene structure and regulation. Members of a family of radiomimetic protein antibiotics, in particular neocarzinostatin (NCS), will be the focus of this investigation. Earlier work has shown that NCS contains a labile nonprotein chromophore of unique structure that possesses all the biological activity, binds to DNA by intercalation, and damages DNA when activated by thiol by selectively attacking C-5' of deoxyribose of mainly thymine residues to produce, in the presence of O2, strand breaks with nucleoside 5'-aldehyde at the 5'-end and phosphoryl at the 3'-end, and base release with the formation of apurinic/apyrimidinic sites, and in the absence of O2 covalent NCS chromophore- deoxyribose adducts. Evidence that a similar mechanism occurs in vivo will be sought by isolating DNA from NCS-treated mammalian cells and analyzing it by various techniques for the presence of the lesions found in vitro. Studies will also be performed 1) to determine the role of microheterogeneity of DNA structure in base sequence-dependent binding of NCS, using chemically synthesized oligodeoxynucleotides of defined sequence, 2) to determine structure-function relationships in the NCS chromophore by chemical modifications, 3) to obtain more detailed information on the molecular mechanism of DNA damage by chemical characterization of damage products (deoxyribose fragments, NCS chromophore-deoxyribose adducts, spent NCS chromophore, etc.), 4) to clarify how nitroaromatic radiation sensitizers, such as misonidazole, substitute for O2 in producing DNA damage, and 5) to characterize possible new enzymatic mechanisms of repair of NCS-induced DNA damage. These studies will be extended to include other related protein antibiotics, notably auromomycin, that have different attack site specificities and produce different DNA damage products.